Activation of matrix metalloproteinase-9 is essential to overcome failed fibrosis resolution

PROJECT SUMMARY
A key feature of interstitial lung diseases (ILDs), including idiopathic pulmonary fibrosis (IPF), is the excessive
deposition of extracellular matrix (ECM) and scar tissue. Fibroblasts persist in fibrotic lungs and lay down matrix,
contributing to a progressive and persistent phenotype in patients. Matrix metalloproteinases (MMPs) are
enzymes that cleave and break down ECM during wound repair and the degradation and removal of scar tissue
is essential for fibrosis resolution. The expression of MMP-9 is increased in the lungs of IPF patients. However,
MMP-9 is not present in the active form rendering it unable to cleave collagens. Our preliminary data in MMP-9
deficient mice support that active MMP-9 is necessary for fibrosis resolution. We therefore asked if MMP-9
activation is inhibited in IPF lungs limiting its ability to successfully initiate repair through matrix degradation.
MMP-9 is activated from its latent-form through a series of activating enzymes beginning with urokinase
plasminogen activating enzyme (uPA). uPA cleaves plasminogen into plasmin which in turn is a major activator
of MMP-9. However, in IPF, plasminogen activator inhibitor-1 (PAI-1) inhibits uPA thus inhibiting the activation
cascade needed for downstream MMP-9-activation and matrix degradation. Due to the poor quality and
significantly reduced life expectancy associated with ILDs, it is becoming increasingly important to identify
molecular pathways that are targetable for therapeutic intervention. This proposal seeks to address this unmet
need by investigating the central hypothesis that MMP-9 activation by plasmin is necessary for fibrosis resolution
and that this pathway can be induced through beneficial TNF-a signaling. Based on our robust preliminary
studies, we propose three specific aims to test this central hypothesis. Specific Aim 1 will test the hypothesis that
beneficial TNF-a signaling increases urokinase and expression of MMP-9 in fibroblasts. This will be tested using
genetic approaches to determine if conditional deletion of MMP-9 in fibroblasts is sufficient to prevent fibrosis
resolution in a spontaneously resolving fibrosis model and if exogenous TNF-a is sufficient to activate the
uPA/plasminogen/MMP-9 pathway, inducing resolution in a non-resolving fibrosis model. Specific Aim 2 will test
the hypothesis that MMP-9 activation by plasmin contributes to the resolution of bleomycin-induced fibrosis. This
will be tested through the generation of a non-cleavable MMP-9 mutant and through pharmacological inhibition
of MMP-9 in vivo. Specific Aim 3 will test the hypothesis that a clinical formulation of recombinant urokinase
(KinlyticTM) promotes the resolution of established pulmonary fibrosis by activating pro-MMP-9 through the
plasminogen/plasmin cascade. This will be tested by treating mice with persistent fibrosis with recombinant
urokinase to induce plasmin and MMP-9 activation as a mechanism of fibrosis resolution. The proposed studies
will provide a novel understanding about how activating an anti-fibrotic pathway (uPA/plasminogen/MMP-9) may
contribute to the resolution of fibrosis. Furthermore, the outcomes of these pre-clinical, therapeutic studies will
significantly impact our understanding of the mechanisms that control fibrosis resolution.

Public health relevance
PROJECT NARRATIVE Pulmonary fibrosis is often a fatal condition that leads to progressive scarring of the lungs, but little is known about inducing matrix clearance and fibrosis resolution in humans. This application seeks to address the pivotal role of MMP-9 activation for matrix degradation via plasminogen/plasmin cascade in fibroblasts. The results of our studies should provide insight into the development of novel therapeutic strategies to induce fibrosis resolution that will improve the outcomes for patients with fibrotic lung disease.